The Lysophospholipid and Related Mediators Conference: From Bench to Clinic

Abstract
The FASEB Science Research Conference on Lysophospholipid and Related Mediators: From Bench to Clinic
will be held July 9 - July 13, 2023 at the Crown Plaza Hotel, Melbourne, Florida, USA. This conference will address
current research and emerging concepts related primarily to the lysophospholipids sphingosine 1-phosphate
(S1P) and lysophosphatidic acid (LPA) and their roles in health and disease. S1P and LPA are signaling lipids
that activate 5 and 6 G protein-coupled receptors, respectively, and bind to intracellular target proteins to regulate
cell biology. These biological interactions control vital functions in the cardiovascular system, the immune system,
and the nervous system. These lipids are important in pulmonary fibrosis, atherosclerosis, cancer, autoimmunity,
and other disease states. Both receptors and enzymes regulating lysophospholipid metabolism have been shown
to function as potential therapeutic targets to diagnose, prevent or treat disease. The conference will emphasize
the translation of this work into clinical practice and highlight the research advances being made at a rapid pace
by many new investigators in this field. The meeting provides a unique and invaluable forum for scientists from
diverse disciplines to meet and discuss their latest research findings. The conference aims are to 1) provide
intellectual exchange between scientists and trainees from multiple disciplines engaged in lysophospholipid
research; 2) encourage and facilitate active discussion between early career and new investigators and
established scientists via interactive career workshops and multiple opportunities for networking/collaboration;
and 3) provide a platform to promote the participation of women and underrepresented minorities. The conference
will allow diverse early career and established investigators to communicate late-breaking research results and
promote future interactions aligned with developing therapies for diseases in which lysophospholipids play a
predominant role. The conference site in Ireland will facilitate maximum participation of European scientists,
scientists from other countries abroad, and US counterparts to promote productive interactions focusing on the
translational implications of lysophospholipids.

Public health relevance
Project Narrative High quality scientific conferences are vital to the public health mission of the NIH. This application requests funding for the biennial FASEB Science Research Conference on Lysophospholipid and Related Mediators: From Bench to Clinic. The purpose of this meeting is to exchange and disseminate information in the field of lysophospholipid signaling and its application to human diseases including cardiovascular diseases, cancer, and autoimmune disorders.